Project 5 - EBV Drivers of Oncogenesis and Novel Therapies

PROJECT 5 – PROJECT SUMMARY/ABSTRACT
Epstein-Barr virus (EBV) latent infection of B lymphocytes in vitro results in their growth transformation;
however, in vivo, the growth of EBV-infected lymphocytes is normally constrained by robust immune
responses against viral antigens. As a result, EBV genes essential for growth in vitro (such as LMP1 and
EBNA2) are often not expressed in EBV-positive lymphomas such as Burkitt lymphoma (BL), Hodgkin
Disease and diffuse large B cell lymphomas. Thus, in vitro transformation studies cannot adequately model
how EBV infection promotes common types of EBV-positive human lymphomas that have more stringent
forms of viral latency. The EBV BARTs microRNAs, and EBNA3A, are amongst the very few EBV-encoded
genes/microRNAs expressed in human BLs, and are likely to play important “driver” roles in this type of
lymphoma. We have shown that BARTs play an important role in maintaining the viability of EBV-positive
BLs in vitro, and in decreasing the immunogenicity of EBV-transformed lymphoblastoid cell lines. The latent
EBNA3A protein encodes a transcription factor that is essential for in vitro growth of EBV-transformed B cells,
and is thought to collaborate with the closely related EBNA3C protein to inhibit expression of important tumor
suppressors (including p16, p15 and BIM) by inducing EZH2-mediated H3K27 trimethylation of their
promoters. However, the roles of BARTs and EBNA3A in promoting EBV-induced lymphomas in vivo have
not been well studied, particularly in the context of lymphomas with more stringent latency. EBV-infected
humanized mice provide sophisticated models for understanding the complex interactions between EBV, T
cells, cellular pathway alterations and the microenvironment. We have recently developed a new cord blood-
humanized mouse model that allows EBV mutants that are non-transforming in vitro (including EBNA2-
deleted EBV) to form lymphomas with stringent viral latency in vivo. We propose to use two different
humanized mouse models to examine the roles of BARTs and EBNA3A for EBV-induced lymphomas in vivo,
and to determine if drugs which block essential EBNA3A functions inhibit lymphoma development. In Aim 1,
we will examine how loss of BARTs affects viral pathogenesis in the context of type III versus Wp-restricted
viral latency, and examine potential mechanisms by which BARTs expression is upregulated in vivo. In Aim
2, we will use the cord blood-humanized mouse model to explore the role of the EBNA3A protein in vivo. In
Aim 3, we will explore the therapeutic potential of drugs (CK4/6 and EZH2 inhibitors) that block essential
EBNA3A/3C-regulated pathways. This project interacts extensively with Projects 3 and 4, and uses the cores
for immunohistochemistry, bioinformatics, and generation of EBV mutant genomes. The results of these
studies should provide key insights into the mechanism(s) by which stringent EBV infection causes
lymphomas in vivo, and may identify new therapeutic approaches for treating EBV-induced lymphomas.

Public health relevance
PROJECT 5 – PROJECT NARRATIVE Epstein-Barr virus (EBV) transforms B cells in vitro, but many EBV-infected human tumors, including Burkitt lymphomas (BLs), contain stringent viral latency types that are not transforming in vitro. In this project, we will use two different humanized mouse models to examine the roles of two different EBV genes/RNAs expressed in human BLs (the virally encoded BARTs microRNAs, and the viral EBNA3A gene), in vivo. In addition, using these models we will ask if drugs that block EBNA3A function inhibit the growth of EBV-induced lymphomas.